Epigenetics-Based Autism Treatment with Animal Models and Human Stem Cells

Summary
This project aims to discover novel pharmacological intervention for core symptoms of autism, including social
deficits and repetitive behaviors. One of the causal factors of autism is the loss of Shank3 gene, which
encodes a scaffolding protein at glutamatergic synapses. We will use Shank3-deficient mouse models and
human stem cell-derived neurons in this drug discovery endeavor. Genetics studies have found that many of
genes disrupted in autism are histone-modifying enzymes that mediate histone methylation/demethylation,
which play a key role in transcriptional regulation. Our preliminary studies have found that histone lysine 4
dimethylation (H3K4me2, linked to gene activation) is significantly decreased in the prefrontal cortex (PFC) of
autistic humans and Shank3-deficient mice. H3K4me2 is demethylated by lysine-specific histone demethylase
1 (LSD1, KDM1A), which is found to be increased in PFC neurons of Shank3-deficient mice. We hypothesize
that inhibiting LSD1 to elevate H3K4me2 and restore gene expression may be able to ameliorate autism-like
phenotypes, therefore providing a novel therapeutic strategy for autism. Combined behavioral, biochemical,
electrophysiological, genomic and stem cell approaches will be used to test this hypothesis. Aim 1, we will
characterize epigenetic changes and therapeutic effects of epigenetic agents in mouse models of autism. The
alteration of histone methylation marks and histone demethylases will also be examined in PFC of Shank3-
deficient mice and autism human postmortem tissues. Aim 2, we will reveal the molecular mechanisms
underlying epigenetic treatment of autism models. Synaptic responses and neuronal excitability will be
recorded in Shank3-deficient mice treated with LSD1 inhibitors. Genome-wide alteration of gene expression
and histone methylation will be examined using RNAseq and ChIPseq. The causal role of identified key
molecules in the therapeutic effects of LSD1 inhibitors will also be determined. In Aim 3, we will examine the
molecular alteration and treatment strategy in human neurons from ASD patient with Shank3
haploinsufficiency. To find out whether the epigenetic treatment strategy found in Shank3 mouse models might
also work in autism patients, we will use the innovative stem-cell technology to examine the capability of LSD1
inhibitors to reverse synaptic deficits and molecular aberrations in ASD patient’s neurons derived from induced
pluripotent stem cells. Results from this study will not only reveal the mechanistic link among important autism
risk factors, but also uncover a mechanism-based treatment strategy for autism.

Public health relevance
Project Narrative This study is to test the hypothesis that targeting histone demethylase LSD1 to adjust gene expression and ameliorate synaptic defects is a novel treatment strategy for autism. Both Shank3-deficient mouse models of autism and human neurons differentiated from stem cells of autism patient with Shank3 haploinsufficiency will be used to test this hypothesis. This study will provide great promise for the discovery of novel pharmacological agents to treat social deficits and repetitive behaviors associated with autism.